Administrative Core

Project Summary - Admin Core
Since the inception of CViSB in 2018, we have built a highly eﬀective administrative structure that is
focused on facilitating communication, collaboration, coordination, outreach, planning, data sharing, and
scientiﬁc and ﬁscal oversight of the component research projects of CViSB. Through the Admin Core we
will oversee all the goals of the Center and ensure their successful, cost-eﬀective, and timely completion.
Staﬃng will be organized via our Management and Staﬃng Plan and outreach activities will be
organized via our Outreach Activities Plan, including organizing our annual CViSB Systems Biology
Workshop. The Admin Core will also organize the ﬁrst Kick-Oﬀ Meeting and Annual Programmatic
Meetings and fund travel and stay for CViSB members. The Admin Core will continue to coordinate and
schedule biweekly Zoom conference meetings among Center sites, and will assist PIs in the preparation
of progress reports, internal compliance ﬁlings, and manuscripts.
The Admin Core will be responsible for the following Speciﬁc Aims: (1) Provide an eﬀective administrative
and leadership structure of CViSB. (2) Organize outreach activities via our Outreach Activities Plan for the
broader scientiﬁc community promoting systems biology approaches for infectious disease research. (3)
Provide eﬀective and responsive lines of communication between CViSB members, NIAID, other SysBio
Centers and the broader scientiﬁc community (4) Facilitate rapid and open source sharing of data and
research resources generated by CViSB (5) Engagement and leadership in cross-center SysBio Program
activities.